Immunogen and Antibody Core

SUMMARY
The use of stabilized envelope trimers as immunogens has greatly advanced the HIV vaccine field, reliably triggering
neutralizing antibodies against tier 2 viruses that represent circulating strains. However, thus far these antibodies have
been strain-specific, and the field needs novel approaches to drive these responses towards breadth. The role of T
cell help in the development of neutralizing Abs has been highlighted in clinical studies of HIV infected individuals who
develop broadly neutralizing antibodies (bNAbs). We hypothesize that vaccine strategies that recruit T cell help for
envelope-based immunogenicity studies (including the fusion peptide) will enhance B cell responses, and that such
help may be augmented by Tfc cells. In the Immunogen and Antibody Core, we will use well-developed SOSIP
platforms to synthesize, purify and characterize advanced HIV envelope (Env) immunogens engineered to drive Tfh
induction and bNAb maturation. These immunogens, including novel fusion proteins to be used in Projects 2 and 3,
will be based on a clade-C 327C derived envelope (MD37), and will be combined with VLPs expressing the fusion
peptide for vaccine studies. SOSIP trimers will be assessed for structural and antigenic integrity and provided as
immunogens and tools for downstream analyses to Projects 2 and 3. The core will also provide the tools and
technologies to assess binding and neutralizing antibodies as well as Fc effector function in human samples from
broad neutralizers in infection cohorts and clinical trial participants, as well as human B cells derived from co-culture
and organoid studies (Project 1). In Projects 2 and 3, Core 1 will assess humoral responses in non-human primate
(NHP) plasma from immunogenicity studies comparing multiple vaccine platforms (Projects 2 and 3). Supporting
Projects 1, 2 and 3, we will also perform detailed bioinformatic analyses of vaccine-induced or organoid-derived B
cells, to assess the maturation of humoral responses. Finally, these data will be provided to the Data Monitoring and
Analysis Core (DMAC) to integrate datasets and define correlates of immunity. Overall, our highly experienced core
is well placed to use an array of serological, structural and genetic approaches to provide a comprehensive profile of
binding and neutralization activity in sera from infection, vaccination and B cell cultures.

Public health relevance
Project Narrative A major challenge in the HIV vaccine field is determining how to elicit antibodies that can block HIV infection. Studies of HIV infection, where rare people make the correct antibodies, have shown that specialized T cells, called Tfh cells, are important in supporting the B cells which make antibodies. However few vaccine strategies target both arms of the immune system – providing B cells with T help. Furthermore, the potential contribution of Tfc cells to B cell maturation is unknown. This program aims to fill these gaps. Core 1 will provide the antibody readouts needed to define the contribution of Tfc and Tfc to B cell maturation in infection and vaccination. The core will also make and characterise the protein immunogens for vaccine studies, and measure the immune response is to the novel vaccines being tested here.